Tailored Treatment Strategies for Patients with Chronic Limb Threatening Ischemia

PROJECT SUMMARY
Consistent with the research priorities of the National Heart, Lung, Blood Institute, this
proposed study will investigate optimal treatment algorithms for patients with chronic limb
threatening ischemia (CLTI). CLTI is the most severe, debilitating, and progressive form of
peripheral artery disease. Successful treatment requires ongoing combinations medical,
wound/podiatric, and endovascular or surgical vascular care. Despite the availability of multiple
life- and limb-preserving treatments, success in improving health outcomes of patients afflicted
with CLTI has been limited. Several patient factors influence the effectiveness of treatments
over time: socioeconomic conditions, adherence to best medical therapy, degree of success
with revascularization, and ability to attend postoperative vascular surveillance appointments. A
lack of understanding of how these clinical and social factors affect CLTI treatment sequences
and impact CLTI-free survival is a critical barrier to saving lives and limbs.
The recently completed NHLBI-sponsored BEST-CLI randomized controlled trial with 1830
adult participants determined that surgical vein bypass is the most effective initial
revascularization approach for patients with CLTI, but almost 10% required major vascular re-
intervention, 10% underwent major limb amputation, and 33% died within two years. Our
proposed research will use advanced analytics and machine learning to leverage the BEST-CLI
trial data to identify the patient characteristics that associate with different disease trajectories
and treatment patterns after the initial revascularization (Aim 1). Aim 2 will measure the effect of
partial adherence to clinical follow-up visits on these clinical trajectories and CLTI-free survival.
The identified patterns will define treatment tailoring opportunities- key decision points at which
treatment decisions can be customized to individuals based on their unique clinical features.
To address the non-clinical factors that influence treatment adherence and CLTI outcomes,
Aim 3 is a prospective qualitative study, including semi-structured interviews and a user-
centered design approach called journey mapping, that will identify facilitators, gaps and unmet
needs that impact patients’ ability to adhere. This will inform where additional support should be
integrated to make individualized, optimal treatment plans accessible to all patients.
Our final output will include individually tailored, socially supportive treatment plans that
improve the health of patients with CLTI. In the future, these candidate treatment algorithms will
be tested with sequential multiple assignment randomized trials (SMARTs) to realize the goal of
bringing precision medicine (“right treatment, right person, right time”) to CLTI care.

Public health relevance
PROJECT NARRATIVE Chronic limb threatening ischemia is a condition with increasing prevalence in the United States that puts patients at a high risk for developing wounds, limb loss, and death. Treatment is complex and involves medications, wound care, and surgical or endovascular revascularization. The results of this study will provide testable treatment algorithms designed to optimize limb preservation and survival over the longitudinal course of care.